Study of Interleukin 33 as a new immunotherapy of lung cancer

The immune suppressive tumor microenvironment (TME) has limited the response rate of Immune checkpoint
blockade (ICB) therapy. Lack of immune stimulatory “danger” signal molecules in TME can be a major factor
contributing to resistance to tumor immunotherapy. Therefore, reprogramming the TME by over-expression of
alarmin represents a novel and promising tumor immunotherapy. We have found that IL-33, which is a
“danger” signal, is expressed in normal lung epithelial cells but drastically down-regulated in human malignant
lung cancer cells. Our bioinformatics analysis of the TCGA data has suggested that loss of tumor protein p53
(TP53) is responsible for IL-33 down-regulation in epithelial cells during tumorigenesis of multiple human
cancers. In addition, IL-33 expression was reduced in p53 deficient compared to p53 WT murine lung tumor
cells. These data suggest that down-regulation of IL-33 is a major mechanism of tumor immune evasion. Using
mouse tumor models, we demonstrated that IL-33 was highly expressed in immunogenic murine tumor cells
and its level could be further increased during ICB tumor therapy. Importantly, we showed that the ST2/IL-33R
signaling was required for therapeutic effect of ICB therapy. Furthermore, we showed that tumor tissue
expression of IL-33 synergized with both chemotherapy and ICB in inhibiting lung tumor growth. And the
increased therapeutic efficacy was associated with increases in function and number of CD103+CD8+ T cells
as well as decreases in Treg. We hypothesize that a novel immunotherapy based on reprogramming TME by
“alarmin” IL-33 synergizes with chemotherapy and ICB immunotherapy through promoting tumoral
CD103+CD8+ T cells. SA1. Test the hypothesis that loss of the tumor suppressor gene p53 causes the down-
regulation of epithelial IL-33 expression, leading to reduced tumor immune surveillance of lung tumor and
accelerated lung tumor progression. SA2. We will focus on development of an improved therapy that is based
on codelivery of IL-33 expressing plasmid and paclitaxel (PTX), alone or in combination with either PD1 mAbs
or CTLA-4 mAbs-based ICB.

Public health relevance
Narrative Cancer immunotherapy has been shown recently to be a promising modality of cancer therapy. Current proposal is aim to boost antitumor immunity by delivering a potent antitumor cytokine IL-33 to cancer tissues.